ALKBH5 and nickel-induced lung carcinogenesis

Project Summary
Nickel compounds are well-established human carcinogens. Epidemiological studies have reported an
increased incidence of lung and nasal cancer following long-term exposure to nickel compounds due to either
environmental or occupational exposure. Growing evidence indicates that alterations of the epigenetic
landscape, including DNA methylation and histone modification, are important mechanisms in nickel-induced
lung carcinogenesis. However, the impact of nickel exposure on the epitranscriptome and the potential role of
RNA modification in nickel carcinogenesis have never been explored. Our preliminary studies discovered that
human bronchial epithelial cells exposed to nickel compounds exhibited reduced mRNA stability of maternally
expressed gene 3 (MEG3), an imprinted gene that was downregulated in many types of tumors and a strong
driver for nickel-induced malignant transformation. In addition, nickel upregulated m6A demethylase ALKBH5
mRNA and protein expression that coincided with MEG3 RNA destabilization, suggesting ALKBH5 may
contribute to cell transformation via modulating global- or gene-specific m6A abundance. Moreover, knockdown
of ALKBH5 completely abolished MEG3 degradation in nickel-exposed cells, suggesting that RNA methylation
may play a role in protecting MEG3 stability. However, it is not clear how nickel upregulates ALKBH5 as well as
whether increased ALKBH5 mediates nickel-induced cell transformation. Additionally, how m6A abundance
modulates MEG3 RNA stability remains largely unknown. Therefore, in this application, two specific aims were
proposed to address the key events in nickel-induced MEG3 destabilization. The first aim will address whether
increased ALKBH5 is sufficient to induce malignant transformation in vitro. The second aim will target the
potential upstream regulators and downstream effectors that mediate nickel-induced ALKBH5 expression and
MEG3 destabilization. To the best of our knowledge, this is the first proposal to tackle the impact of environmental
nickel exposure on the changes of m6A enzymes as well as transcriptome-wide or gene-specific m6A
methylation profiles. Success of this proposal will facilitate our understanding of how nickel targets RNA
modification enzymes or RNA binding proteins to initiate or promote lung tumor formation, and further identify
new aspects of m6A enzymes as a prognostic biomarkers or therapeutic targets to improve clinical outcomes of
lung cancer patients.

Public health relevance
Project Narrative Oxidative nickel compounds are well-established human lung carcinogens. This proposal aims to investigate the functional role of N6-methyladenosine (m6A) and its demethylase ALKBH5 in nickel-induced malignant transformation and lung carcinogenesis. The success of this research proposal will significantly improve our understanding of the mechanism of nickel lung carcinogenicity and provide new aspects on m6A demethylase as a prognostic biomarker or therapeutic target to improve clinical outcomes of lung cancer.